Bio-Imaging Core

PROJECT SUMMARY – BIOIMAGING & CONFOCAL MICROSCOPY
The Bioimaging & Confocal Microscopy core at OHSU will provide instrumentation and support for fluorescence
and confocal microscopy, as well as rodent optical coherence tomography (OCT) to enhance and facilitate vision
research at OHSU. The major instrumentation and expertise are already in place at the Casey Eye Institute
(CEI). Past P30 support of imaging systems at the CEI has been extremely successful, with data from the
supported instruments featuring in 45 publications during the previous 4-year funding period. Dr. Catherine
Morgans and Dr. Ben Sivyer are both experts in confocal and fluorescence microscopy and will serve as co-
Directors of the Bioimaging & Confocal Microscopy core. Dr. Renee Ryals, an expert in rodent OCT, will provide
guidance and training to new OCT users. Training opportunities and access to instruments will be available to
all principal investigators, postdoctoral fellows, and graduate students engaged in vision research at OHSU.